A mechanistic investigation of SerpinB3 and its role in psoriasis

SUMMARY
Psoriasis vulgaris (or plaque psoriasis) is a chronic skin disease affecting 2-3% of the worldwide population and
the most common manifestation of psoriasis. Though psoriasis has a low mortality rate, it is strongly associated
with several potentially deadly comorbidities, including several cancers, and psoriasis patients experience
significantly elevated levels of depression, anxiety, and completed suicide. There is a recognized unmet need
for new treatments against moderate-to-severe psoriasis due to the development of treatment inefficacy and
high costs for more effective, second-line treatments. Despite substantial progress in characterizing the
molecular mechanisms of psoriasis, the molecular events stimulating the initiation and pathogenesis of plaque
psoriasis remain unknown. While inflammation, particularly Th17-driven, has gained attention, there is significant
ongoing debate about the role of both immune dysregulation and keratinocyte dysfunction in the onset and
progression of psoriatic disease, and investigation of druggable factors from keratinocytes is warranted.
SerpinB3 is a keratinocyte-expressed serine protease inhibitor with substantial evidence for a potential
mechanistic role in psoriasis. SerpinB3 is highly upregulated in the skin of patients with psoriasis and the
misprocessed form of SerpinB3, Pso p27, is the dominant autoantigen found in the protein mass of psoriatic
plaque scales. However, despite robust and suggestive evidence no studies investigating SerpinB3 as the
initiating, etiological agent in the pathogenesis of psoriasis have been reported. This proposal will explore the
hypothesis that misprocessing of SerpinB3 is the initiating agent of psoriasis in three aims. Aim 1 will focus on
mechanistic investigation of SerpinB3 dysregulation in vitro using cell-based studies to understand how SerpinB3
may traffic from keratinocytes to mast cells, which evidences suggests produce Pso p27 despite do not
endogenously expressing SerpinB3, as well as a role for Pso p27 in Th17-driven inflammation. Aim 2 will evaluate
the role of mouse ortholog Serpinb3a in the pathogenesis of psoriasis with the imiquimod-induced psoriasis
model in wildtype, Serpinb3a-deficient, and mast cell-deficient mice. Further, an investigation of whether Pso
p27 is the etiological agent of psoriasis will be undertaken by direct delivery of immune complexes into the skin
of wildtype, mast cell-deficient, and IL-17-deficient mice with no other stimulus. Aim 3 will explore whether
SerpinB3 is a druggable target for the treatment of psoriasis at the transcriptional, translational, and post-
translational levels in both human explanted culture models and mouse models. The success of the research is
supported by a strong, diverse team with complementary scientific expertise in serpin biology, drug delivery,
dermatology, and pathology. This proposal, a new direction for an early-stage investigator PI with established
expertise in serpin biology and relevant techniques, will leverage the innovative and scientifically robust
environment at Arizona State University and neighboring institutions to develop a paradigm-shifting molecular
mechanism of disease in psoriasis with potential for therapeutic targeting with a solid path to clinical translation.

Public health relevance
PROJECT NARRATIVE Psoriasis vulgaris, commonly called plaque psoriasis, is a chronic physically and psychologically destructive skin disease affecting 2-3% of the worldwide population with an ongoing, unmet need for new treatments that do not suffer from prohibitive cost and susceptibility to lose efficacy of existing options. Despite substantial progress in characterizing the mechanisms of psoriasis, the molecular events stimulating the initiation and pathogenesis of plaque psoriasis remain unknown, and considerable evidence points to the potential for a critical role for the serine protease inhibitor SerpinB3, the precursor of the dominant psoriasis autoantigen Pso p27, in initiation of the disease. The proposed research will (1) investigate psoriasis-associated dysregulated SerpinB3 signaling mechanisms in vitro, (2) evaluate the role of the mouse ortholog of SerpinB3 in a model of psoriasis, and (3) assess the therapeutic potential for SerpinB3 modulation in human and mouse models of psoriasis with the overall goal of testing the hypothesis that SerpinB3 is etiological agent in the pathogenesis of psoriasis.